Dynamic population codes for perception

Dynamic population codes for perception
PROJECT SUMMARY
One of the most critical functions of sensory and motor systems is preparation for upcoming events. In sensory
systems, this preparation confers a perceptual and behavioral advantage. When the location of an upcoming
event is known, subjects respond with shorter reaction times and greater accuracy – an internal state that is
often referred to as spatial attention. Numerous regions throughout the cortex have been implicated as playing
important roles in establishing and maintaining attention, making it clear that attention operates through the
coordinated activity of neuronal populations throughout the brain. Typical studies of attention, however, have
focused largely on averaged neuronal responses in a time window well after the time of stimulus onset, and
nearly all have involved recordings from a single brain region at a time. We will investigate the population-level
mechanisms by which neurons prepare for an anticipated stimulus and maintain an attentional state, focusing
on the activity of neurons within visual and prefrontal cortex as well as the interactions between these regions.
Our strategy is to employ population-level measures to reveal signals hidden from single-neuron and averaged
approaches, and then link these measures to behavior. In the first specific aim, we measure how neurons in
visual cortex prepare for an upcoming stimulus. We hypothesize that a diverse population code underlies
attentional preparation in visual cortex and is reflected in the earliest responses. In the second specific aim, we
determine how prefrontal cortex and visual cortex work in concert to prepare attention. We hypothesize that
prefrontal cortex serves to maintain a stable attentional state in the absence of visual stimulation, and
coordinated activity between these regions influences behavior. In the third specific aim, we seek to
understand how preparation in visual cortex is adaptable based on context. We hypothesize that dynamic task
demands influence the patterns by which visual cortex prepares, enabling attention to flexibly influence
behavior in numerous situations. The overall result of this study will be to establish the role of population
activity in dynamic visual perception, and to construct a framework by which to relate population recordings in
multiple brain regions to visual perception and behavior. This will aid in developing treatments for neurological
disorders of vision and rehabilitation after traumatic brain injury or disease.

Public health relevance
Dynamic population codes for perception PROJECT NARRATIVE (RELEVANCE) Damage to visual cortex leads to disorders such as neglect and agnosia. To better diagnose and treat patients, and lay the groundwork for methods to repair the brain or interface with prosthetics, it is crucial to understand neuronal activity and variability and how it is shaped during behavior. The proposed research investigates how visual cortex prepares our attention, a fundamental process by which we filter incoming information and improve our perception and behavior.